GENETICS OF INSULIN SECRETION AND RESISTANCE IN POLYCYSTIC OVARY SYNDROME

This study seeks to determine 1) if beta cell secretory dysfunction is more prevalent among insulin resistant women with PCOS compared to similarly insulin resistant controls; 2) if first-degree relatives of women with PCOS are at increased risk of a) IGT or NIDDM; b) insulin resistance; c) beta cell secretory dysfunction. We also seek to a) character the transmission of beta cell function and insulin sensitivity in families of women with PCOS; b) determine whether the transmission of insulin sensitivity is independent of the transmission of beta cell function; c) characterize the extent to which beta cell dysfunction contributes to the risk imparted by insulin resistance to the development of NIDDM.